Defining the Contribution of Mitochondrial DNA to Viral Infectious Diseases, Type 2 Diabetes, and their Interactions

Mitochondria are at the intersection of metabolism and immunity. Mitochondrial DNA (mtDNA) and nuclear
DNA (nDNA) variants affect mitochondrial function and diseases relevant to Veterans. This project includes a
team with extensive experience studying the genetics of type 2 diabetes mellitus (T2D) and viral infectious
diseases (VID). A new collaboration is proposed to define the mitochondrial genetic associations with and
interactions between these two common and important phenotypes. The overarching hypothesis is that
mitochondrial genetic information available in the Million Veteran Program (MVP) will be associated with T2D
and VID, and will modify interactions between them. Important mechanistic connections through immune
responses (both innate and adaptive) relevant for VID and T2D pathogenesis are regulated in part by
mitochondria. Coronavirus disease 2019 (COVID-19) is a new VID that has infected >600,000 Veterans to date
and highlights the bi-directional intersection between T2D and VID. COVID-19 includes profound immune
dysregulation (particularly interferon [IFN] signaling and responses), metabolic derangements including
exacerbation of T2D, and is also made more severe by these conditions. Several mitochondria-related effects
of COVID-19 have already been reported. MVP genotyping currently contains 20 common and ~130 rare
mtDNA variants in ~650,000 Veterans and will soon include whole genome sequencing (WGS) with more
extensive mtDNA genotyping for 150,000 of these Veterans. This project will characterize, curate, and derive
information from these variants in the MVP by established and novel methods to establish a new resource
(“MitoMVP”) and perform new analyses. The following aims will enhance the understanding of mitochondria-
related VID and T2D interactions, facilitate development of new therapeutic targets, and provide a data
resource to accelerate broader mitochondria-targeted precision medicine efforts. First, MitoMVP, a curated
dataset of mitochondrial genetic information in the MVP including expanded mitochondrial genetic information
on quantity (mtDNA copy number) and quality (predicted pathogenicity) will be established. Next, mitochondrial
genetic information and nDNA genetic variants associated with T2D and VID will be identified, and genetic
interactions between them defined. Finally, phenotypic interactions between T2D and VID that influence
genetic associations will be assessed through stratified analyses focused on severe COVID-19 as a prototype.
Because T2D is a complex phenotype, information in the MVP will be used to define subgroups with T2D-
related clinical and laboratory metabolic phenotypes (e.g., obesity, hyperglycemia, and dyslipidemia/low HDL
cholesterol) for stratified analyses, potentially yielding new associations and important clues to mechanisms of
gene-by-environment interactions. This aim will also include mitochondrial phenome-wide association studies
(PheWAS) to identify novel genotype-phenotype associations of interest, providing additional MitoMVP
information that will be available for future studies by other MVP investigators.

Public health relevance
The proposed project is relevant to Veterans’ health by addressing two important conditions that affect Veterans: diabetes and viral infections. Existing research resources from the Million Veteran Program (MVP) will be used to identify relationships between genetic differences and risk of diabetes and infections. New information will be obtained from this existing genetic data that will help identify new factors related to diabetes and infections, including COVID-19. These data can then be used by other researchers in the future. This study will lead to new ways to understand risk for diabetes and infections in Veterans, and will inform future studies of new ways to prevent and treat these conditions.